Extending Digital Survivorship Needs Assessment Planning Tools to Enhance Communication in the Head and Neck Cancer Survivor-Caregiver-Provider Triad

PROJECT SUMMARY
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
23-041. Head and neck cancer (HNC) survivors and their caregivers experience devastating physical, emotional
and social challenges at the end of treatment. Dyadic interventions are needed to address dyads’ unique needs
and link them to timely healthcare and supportive care resources. The survivorship needs assessment planning
(SNAP) digital health tool includes a comprehensive needs assessment for survivors and caregivers, tailored
care plans and a supportive App. To prepare SNAP for wide dissemination, in the proposed research we will
improve understanding of how to share SNAP care plan and App data across survivors, caregivers and multi-
disciplinary healthcare providers to ultimately improve care experiences. We will examine SNAP’s effects on
communication and patient-centered care and characterize best practices to promote SNAP information-sharing
within the survivor-caregiver-provider triad. Using a participatory approach and mixed methods with survivors,
caregivers, multi-disciplinary oncology and community providers and clinic and information technology
administrators, the specific aims of this administrative supplement are to 1) evaluate the capacity of SNAP and
mechanisms to improve survivor-caregiver-provider communication guided by the Unified Theory of Acceptance
and Use of Technology and 2) characterize optimal implementation strategies for integrating SNAP care plan
and App data into clinical workflows (e.g., patient portals, electronic health record prompts, alerts and reports for
oncology specialists and primary care providers) to enhance survivor-caregiver-provider communication. SNAP
seeks to enhance patient-centered car by assessing and addressing survivor and caregiver needs and values.
This supplement will enhance the parent study by extending our research to take the critical next steps in
evaluating the potential and mechanisms underlying SNAP’s impact on communication and receipt of patient-
centered care. The study will improve the delivery of SNAP and result in products (e.g., protocols, prompts, App
alerts and summary reports) to ensure the timely use of SNAP data in practice.

Public health relevance
PROJECT NARRATIVE Head and neck cancer (HNC) survivors and their caregivers experience unique and significant physical, emotional and social challenges at the end of treatment. The survivorship needs assessment planning (SNAP) digital health tool includes a comprehensive needs assessment for survivors and caregivers, tailored care plans and a supportive App for dyads. To prepare SNAP for wide dissemination, in this research we will improve understanding of how to share SNAP care plan and App data across survivors, caregivers and multi-disciplinary healthcare providers to ultimately improve care experiences.